HIV risk, PrEP disparities, and stigma among Women who use Drugs in the U.S. South, with attention to race and sexual orientation: A mixed-method intersectionality study

PROJECT SUMMARY/ABSTRACT
HIV infection among cisgender women who use drugs (WWUD) in the US South is a critical public health
issue. WWUD with diverse marginalized identities (e.g., Black heterosexual, White sexual minority) experience
intersectional stigma uniquely, which can result in HIV risk/protective behavior (e.g., condomless sex, social
support) and impact access to HIV prevention healthcare resources (PrEP). WWUD are PrEP indicated, but
their PrEP continuum outcomes (i.e. awareness, acceptability, uptake) remain low. WWUD have complex
proximal (e.g., syringe sharing) and distal (e.g., intersectional stigma experiences in healthcare settings) HIV
risk/resilience experiences that require further examination to develop effective interventions. Intersectionality
theory, undergirding this proposal, acknowledges interlocking power dynamics (e.g., racism) playing out in
social processes (e.g., intersectional stigma) to impact health outcomes and disparities. The proposed mixed-
method research aims to study HIV risk/resilience, healthcare barriers/facilitators, and PrEP continuum
disparities among WWUD in the US South, employing an intersectional strengths-based analytical lens to
inform multi-level stigma-reduction, HIV prevention, and PrEP promotion initiatives. To do so, I will first
describe HIV risk and PrEP continuum disparities by identifying WWUD subgroups based on intersectional
identity (i.e., race X sexual orientation) and contextual factors (e.g., sex exchange) using intersectional
quantitative approaches gained from training (e.g., latent class analyses) with southern National HIV
Behavioral Surveillance data (Aim 1). Next, I will explore multi-level barriers/facilitators (e.g., intersectional
stigma) in HIV prevention-related healthcare, HIV risk, and PrEP continuum via qualitative healthcare go-along
interviews with a purposively selected sample of PrEP indicated WWUD in New Orleans, LA (Aim 2).
Subsequently, I will explore institutional practices related to WWUD identified barriers/facilitators to HIV
prevention-related healthcare seeking, HIV risk, and PrEP continuum utilizing institutional ethnography (Aim 3).
This proposed research will facilitate application of training objectives towards my long-term career goal of
becoming an independent NIH-funded HIV prevention and health equity investigator. My career development
plan, including an expert team of mentors, (Drs. Latkin, Bowleg, Theall, German, Baral), centers the following
training objectives: 1) develop comprehensive expertise in intersectionality theory application, associated
mixed-methods study design approaches, and advanced ethnographic methodology (e.g., go-along
interviews); 2) develop advanced statistical theory and methods to conduct quantitative intersectionality
analyses(e.g., latent class analysis); 3) gain expertise in multi-level intersectional stigma theory and
ethnographic methods(e.g., institutional ethnographies); and 4) develop skills needed for a successful
academic career in intersectional mixed-method HIV prevention research with vulnerabilized populations (e.g.,
research bioethics, multi-stakeholder dissemination, grant writing; and interdisciplinary networking).

Public health relevance
PROJECT NARRATIVE HIV infection among cisgender women who use drugs (WWUD) in the US South is a significant public health issue; WWUD with diverse marginalized identities (e.g., Black heterosexual, White sexual minority), have complex proximal (e.g., syringe sharing) and distal (e.g., intersectional stigma experiences in healthcare settings) HIV risk/resilience experiences that require further examination to develop effective interventions. Through the proposed mixed-method research we will 1) describe HIV risk and PrEP continuum disparities among WWUD in the US South by identifying subgroups of WWUD based on intersectional identity (e.g., Black heterosexual woman) and contextual factors (e.g., sex exchange); 2) explore multi-level barriers/facilitators (e.g., intersectional stigma, social support) in HIV prevention-related healthcare, HIV risk, and the PrEP continuum among WWUD sub-populations; and 3) explore institutional practices related to WWUD identified multi-level barriers/facilitators to HIV prevention-related healthcare seeking, HIV risk, and the PrEP continuum. Successful completion will yield empirical evidence regarding unique HIV risk/resilience experiences experienced by WWUD sub-groups critical insights to inform multi-level intersectional stigma-reduction, HIV prevention, and PrEP promotion initiatives.